Treating Common Mental Disorders in Women in Mozambique by Addressing Intimate Partner Violence in Couples

Intimate partner violence (IPV), a potent risk factor for depression, anxiety, and Post-traumatic Stress
Disorder (common mental disorders; CMDs), is a devastating public health problem with the highest rates
occurring in sub-Saharan Africa. Mental health interventions that aim to reduce IPV often fail to include men,
which could be addressed by treatment in a couple modality. Yet, couple-based treatments often exclude
couples who are living with IPV. The goal of this K23 Award is to expand the candidate’s skillset and prepare
her to conduct independent research on couple-based mental health interventions for CMDs that address
social determinants, such as IPV, to improve mental health outcomes and sustainability of gains. The proposed
training program involves mentorship from leading experts, coursework and workshops, attending and
presenting at scientific conferences, and developing collaborative manuscripts for publication to develop
competency in (1) engagement and mental health treatment of men; (2) adaptation of an evidence-based
treatment for CMDs to address IPV in couples; (3) methods and analyses of randomized controlled trials for
couples; and (4) skills for a successful career as an independent investigator.
These training goals and activities will align with the aims of a research study in Mozambique, one of
the poorest countries in the world with a significant mental health treatment gap. Half of women in Mozambique
endorsed being exposed to IPV in the past year, and there are high prevalence rates of CMDs. The candidate
is Project Director of PRIDE (Partnerships in Research to Implement and Disseminate Sustainable and
Scalable EBPs, U19MH113203), a collaborative project with the Mozambique Ministry of Health that is scaling-
up comprehensive mental health care across a province using Interpersonal Counseling (IPC) to treat CMDs.
Scale-up, however, has not considered the coordinated treatment of CMDs and the co-occurring problem of
IPV among couples. The overall goal of the research plan is to investigate the feasibility of reducing CMDs in
women through a couple-based treatment that addresses CMDs and situational IPV (discord between intimate
partners that escalates to physical violence). This study has three specific aims. The first aim is to identify
gender roles including local contextual influences relevant to engaging men in couple-based treatment of IPV
in public MH care. The second aim is to adapt IPC-C to reduce CMDs in female partners through resolution of
IPV and improvement of couple functioning. The third aim is to determine acceptability and feasibility of using
Interpersonal Counseling for Couples (IPC-C) to reduce CMDs in women and IPV in couples. This study has
applicability for low-resource populations internationally and the US that experience couple-based violence and
a mental health treatment gap. With its focus on intimate partners, the intervention also has the potential to
benefit health and wellbeing of children.

Public health relevance
PROJECT NARRATIVE Adapting mental health treatments to address modifiable interpersonal problems has the potential to improve and sustain outcomes in low-resource settings where treatment gaps persist. This K23 Award will prepare the candidate to become an independent investigator with high-impact public health research and expertise in couple-based interventions that address interrelated mental health problems and intimate partner violence in couples by gaining expertise in engagement and treatment of men, adapting an evidence-based treatment for common mental disorders to address IPV in couples, designing and conducting randomized controlled trials with couples, and professional skills development. This work has applicability for low-resource low-income countries and US populations that experience couple-based violence and the mental health treatment gap. With its focus on intimate partners, the intervention also has the potential to benefit health and wellbeing of children.